Fusing motor neuroscience and artificial intelligence to create next-generation neural prostheses.

ABSTRACT
People with disabling motor disorders rely on assistive devices and caregivers for many of their most basic
needs. Current assistive devices are inherently limited, as they rely on (and encumber) residual motor function
as a command interface. Brain-machine interfaces (BMIs) provide a pathway to more powerful assistive options
by directly monitoring brain activity and using it to decipher movement intention in real-time. However, BMIs have
yet to achieve performance and robustness that would warrant widespread clinical adoption. A key obstacle is
that nearly all BMIs to date use direct decoding, i.e., they attempt to map the activity of brain areas like motor
cortex (MC) directly onto external movement parameters such as velocity. This has resulted in BMIs that are
brittle: they often fail in new contexts, and are highly sensitive to neural interface instabilities. Instead, I envision
a radically different approach with the potential to impact virtually every existing BMI application. The central
element is dynamical systems decoding (DSD), a framework I developed that fuses advances in motor
neuroscience with cutting-edge AI methods to achieve unprecedented decoding accuracy. DSD uses neural
networks to precisely reveal MC's complex internal activity patterns, known as dynamics, on a moment-by-
moment basis. This enables a clean separation between activity related to internal dynamics and activity related
to external movement parameters. In offline analyses, I showed that DSD enables a breakthrough in decoding,
predicting movements on millisecond timescales with substantially higher accuracy than the current state-of-the-
art. A key focus of this proposal is developing universal, subject-independent BMIs that harness the remarkable
similarities in MC dynamics observed across subjects. Using new AI methods to model more than a decade of
previously-collected monkey data, we will test whether subject-independent models can enable BMIs that work
nearly `out of the box', with performance that could only be achieved through massive datasets, while still
avoiding burdensome, subject-specific calibration. In parallel with offline studies, we will work directly with people
who are paralyzed to develop online BMIs with unparalleled performance and robustness. Performance
improvements will be achieved through hybrid decoding paradigms that capitalize on high-level movement
information that is uniquely uncovered via DSD. While BMI robustness is typically limited in direct decoding –
due to gradual changes in the specific neurons being monitored – DSD will enable robust BMIs by leveraging
MC dynamics, which are stable for years and independent of whichever specific neurons are being monitored at
a given time. These two innovations would enable BMIs that achieve unprecedented performance and on-
demand, 24/7 reliability for years. If successful, these studies will pave the way to dramatically improving the
performance, robustness, and clinical utility of nearly every BMI application.

Public health relevance
PUBLIC HEALTH STATEMENT Brain-machine interfaces (BMIs) provide a pathway to restore function for people who are paralyzed, such as those with spinal cord injury or amyotrophic lateral sclerosis. This proposal aims to substantially increase the performance and robustness of BMIs by combining new developments from the field of artificial intelligence with recent advances in our understanding of brain function, with the goal of improving quality of life for people with severe movement disabilities.